Enhanced Sympathoexcitation and Inactivity: Role of NMDA Neuroplasticity in RVLM

DESCRIPTION (provided by applicant): Physical inactivity is a major risk factor for cardiovascular disease, the leading cause of death in the United States. Several inactivity-related cardiovascular diseases such as obesity and hypertension are characterized by increased blood pressure and activity of the sympathetic nervous system. The sympathetic nervous system is primarily controlled by an important brain region known as the rostral ventrolateral medulla (RVLM). Despite increasing rates of physical inactivity and cardiovascular disease in our society, there is very little known about how this brain region changes over time in individuals that are physically active versus those that remain sedentary. This lack of knowledge about how physical inactivity may contribute to cardiovascular disease by effects on this important brain region represents a fundamental gap in our field. This research proposal will study the changes that occur over time in regulation of the cardiovascular system by the RVLM in sedentary versus physically active animals. Recent data from the Sponsor's laboratory has shown that the response to activation of the RVLM is enhanced in sedentary relative to physically active animals. Over activity of the RVLM could be a key contributor to the overall elevation in sympathetic nervous system activity that is seen in many cardiovascular diseases. The central hypothesis of this proposal is that physical inactivity enhances, and physical activity reduces sympathetic activation produced by the RVLM. This central hypothesis is based on strong preliminary and published data from the Sponsor's laboratory. This project will determine central nervous system mechanisms by which a sedentary lifestyle may contribute to cardiovascular disease. This proposal utilizes an experimental design that will examine time-dependent changes that occur under sedentary conditions. Active animals will be considered the healthy control, and sedentary animals the disease model. As a whole, this proposal addresses a fundamental question regarding the effect of physical inactivity on regulation of sympathetic nervous system activity by the brain stem and is a key step in understanding the contribution of physical inactivity to cardiovascular disease.

Public health relevance
Project Narrative This research plan is relevant to public health because it will investigate the effects of physical inactivity (a major independent risk factor for cardiovascular disease) on central nervous system control of blood pressure. We expect to determine mechanisms by which a sedentary lifestyle can contribute to the development of cardiovascular disease and provide knowledge that will lead to better prevention and treatment of cardiovascular disease. __SpecificAimsTextDelimiter__ Specific Aims: The rostral ventrolateral medulla (RVLM) is considered the major brain region involved in the tonic and reflex mediated control of blood pressure via its effects on sympathetic nerve activity. Overactivity of RVLM neurons is believed to contribute to elevations in sympathetic nerve activity in various physiological and pathophysiological states. Recent work from the Sponsor’s laboratory suggest that sedentary versus physically active conditions enhance responses to activation of neurons in the RVLM and sympathetic nervous system output. Although this type of “activity-dependent neuroplasticity” has been shown to occur in brain regions involved in cognitive function, the relationship of changes in the RVLM and to cardiovascular health are unknown. This lack of mechanistic knowledge about how physical activity and inactivity contribute to cardiovascular health and disease represent fundamental gaps in the field. This research proposal takes advantage of a recent paradigm shift by us and others that designates sedentary animals as the experimental, “disease” group and physically active animals as the healthy, “control” group. The overall objective of this application is to determine the time-dependent mechanisms by which physical inactivity (versus physical activity) increases sympathetic output from neurons in the RVLM. The central hypothesis of this proposal is that physical inactivity enhances, and physical activity reduces sympathoexcitation by the RVLM via glutamate receptor-mediated neuroplasticity. This project will reveal central nervous system mechanisms by which a sedentary lifestyle may contribute to cardiovascular disease. Furthermore, it is one of the first to determine these mechanisms in the context of neuroplasticity at the level of the RVLM. This proposal is innovative because it examines neuroplasticity in sedentary and physically active animals over time. The results of this study aim to show how physical inactivity can produce changes in the brain that may predispose an individual to developing cardiovascular disease. To test our central hypothesis and achieve our overall objectives, we will pursue the following specific aims: SPECIFIC AIM #1: Determine the time dependent changes by which physical inactivity affects sympathoexcitation produced by ionotropic glutamate receptors in the RVLM. We hypothesize that, relative to active rats, sedentary animals will exhibit a time dependent enhancement in sympathoexcitation mediated by ionotropic NMDA receptors in the RVLM. SPECIFIC AIM #2: Determine the time dependent changes by which physical inactivity affects the expression of ionotropic glutamate receptor subtype subunits in the RVLM. We hypothesize that, relative to active rats, sedentary animals will exhibit a time dependent upregulation of NMDA receptor subunits in the RVLM which is associated with enhanced sympathoexcitation. This proposal addresses the goals of the National Heart, Lung, and Blood Institute in that it provides a mechanism for training the applicant in the field of cardiovascular physiology. This application is an original and innovative approach that addresses a fundamental unanswered question regarding the development of cardiovascular disease in sedentary individuals.